Them1-Mediated Metabolic Regulation and Pathogenic Role in MASLD

PROJECT SUMMARY/ABSTRACT
Overnutrition is central to the pathogenesis of metabolic dysfunction-associated steatotic liver disease
(MASLD). This research proposal addresses the unanswered question of how molecular mechanisms that
normally promote energy conservation become maladaptive and promote MASLD in response to overnutrition.
The long-term goal of this research is to understand the regulatory relationships between cellular lipid
molecules and metabolism. The objective of this research is to understand fundamental mechanisms for the
regulation of energy homeostasis and nutrient metabolism. Our central hypothesis is that Them1 conserves
energy by limiting thermogenesis in brown and beige adipose tissue through its functions both as a lipid-
regulated enzyme that reduces rates of fatty acid oxidation, and as a transcriptional co-regulator. In obesity, we
postulate that Them1 becomes maladaptive. In addition to limiting energy expenditure in thermogenic adipose
tissue, high fat diet-induced Them1 upregulation in liver leads to steatosis and excess gluconeogenesis. The
rationale for the proposed research is that the mechanisms by which Them1 limits energy expenditure, while
promoting hepatic steatosis and insulin resistance, will reveal specific new targets for the management of
MASLD. Guided by extensive preliminary data, the central hypothesis will be tested in three specific aims: 1)
To establish the mechanisms by which Them1 regulates triglyceride metabolism; 2) To elucidate transcriptional
regulation of nutrient homeostasis by Them1; and 3) To delineate lipid-mediated regulation of Them1 cellular
and enzymatic activities. In Aim 1, we will utilize biochemical and biophysical approaches to test the hypothesis
that dynamic formation of membrane free biomolecular condensates (puncta) and their dissolution in brown
adipose tissue provides a tissue-specific physiological mechanism for rapid suppression of thermogenesis. We
will define whether static puncta are responsible for Them1-mediated regulation of hepatic lipid droplets. Aim 2
will test the hypothesis that enzymatically active Them1 within the nucleus regulates gene transcription. Using
mouse models and cell culture systems, we will leverage recombinant adeno-associated virus to express wild
type and Them1 mutant constructs that probe the influence of cellular localization and enzymatic activity on
gene transcription profiles. We will define nuclear interacting partners for Them1 in liver and brown adipose
tissue that contribute to the regulation of nutrient homeostasis. Aim 3 will test the hypothesis that lipid
molecules bind and regulate the cellular localization and enzymatic activity of Them1. We will determine
whether bound lysophosphatidylcholines and fatty acids control the exposure and functional utility of a nuclear
localization signal located within the Them1 START domain. We will elucidate the allosteric control of Them1
activity by lipid binding. Overall, this proposal will elucidate Them1-mediated metabolic regulation, which is
significant because mechanisms that conserve energy in health may promote disease in response to
overnutrition. These studies are expected to identify therapeutic opportunities for the management of MASLD.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the discovery of new mechanisms that regulate energy homeostasis and nutrient metabolism will provide novel insights into the pathogenesis of obesity-related disorders. The proposed studies are relevant to the mission of the NIDDK because they are expected to identify new therapeutic targets for the management of metabolic dysfunction-associated steatotic liver disease.